Conventional and unconventional GPCR-G protein coupling

PROJECT SUMMARY/ABSTRACT
G protein-coupled receptors (GPCRs) are important targets of hormones, neurotransmitters and approximately
one-third of FDA-approved drugs. These receptors signal by coupling to transducer proteins from four families
of heterotrimeric G proteins and a family of four arrestins. Recent structural and functional studies have defined
a conventional allosteric mechanism whereby ligand binding to receptors promotes activation of G proteins and
arrestins. However, there is extensive functional diversity across hundreds of GPCRs and sixteen G proteins,
and many examples of physiology and pharmacology do not conform to the conventional model. For example,
we have found significant variability in the mechanism whereby GPCRs select appropriate G proteins, and
some receptors that recognize unconventional G protein determinants for selectivity. We have also found some
receptors that paradoxically inhibit G protein signaling instead of the usual activation, a type of GPCR-G
protein coupling that is unproductive. Finally, we have found receptors that associate with G proteins prior to
ligand binding and on average release G proteins after activation, a type of inverse coupling that can explain
the unusal pharmacology of such receptors. A complete understanding of GPCR-mediated signaling will
require a better understanding of these unconventional GPCR-G protein coupling mechanisms. In addition, it
will be necessary to translate molecular studies carried out with overexpressed molecules in model cells to
endogenously-expressed GPCRs and G proteins in their native context, where expression levels, stoichiometry
and subcellular compartmentalization more closely match the in vivo situation. Accordingly, we will carry out
studies to map unconventional selectivity determinants, determine the prevalence and physiological
significance of unproductive and inverse GPCR-G protein coupling, and to better understand the
conformational dynamics of GPCRs in cell membranes, and how this conformational landscape changes as
receptors bind ligands and interact with transducer molecules.
This supplement request will support acquisition of a BMG Labtech Omega plate reader, which will be
essential for studying endogenously-expressed GPCRs, G proteins and effectors in their native context in real
time. This instrument is the only one available with the capacity to monitor bioluminescence resonance energy
transfer (BRET) with high temporal resolution.

Public health relevance
PROJECT NARRATIVE About 40% of prescribed drugs target G protein-coupled receptors (GPCRs), which activate transducer proteins called G proteins and arrestins to produce effects that can be either beneficial or detrimental to human health. It is not known how GPCRs select the correct transducers needed to produce appropriate cellular or therapeutic responses, or how the cellular context affects this molecular mechanism. This project aims to increase understanding of how GPCRs interact with their transducers to produce coordinated cellular signals, and may facilitate the development of drugs with the capacity to fine-tune cell signaling and better treat disease. This supplement request will support acquisition of a BMG Labtech Omega plate reader, which will be essential for studying endogenously-expressed GPCRs and G proteins in their native context in real time. This instrument is the only one available with the capacity to monitor bioluminescence resonance energy transfer (BRET) with high temporal resolution. This supplement request will not change the scope of the project. The requested equipment will replace existing equipment that was used for the project but recently failed.